MOBILIZE: Mobility & Transportation Solutions to Improve Hemodialysis Access

PROJECT SUMMARY
5.8 million individuals miss or delay medical care because of a lack of transportation. Persons with end stage
kidney disease (ESKD) particularly depend on reliable transportation to dialysis sessions. In 2022, 84% of
individuals newly diagnosed with ESKD initiated their treatment at an in-center hemodialysis (HD) facility,
requiring they travel three times a week for HD. Yet 10% of patients with ESKD treated with HD miss dialysis at
least monthly, and 35% miss treatment at least once every three months. Missing dialysis has significant
individual and health system consequences, including increased emergency department visits,
hospitalizations, and premature mortality and contributes to persistent racial and socioeconomic disparities in
ESKD prevalence and outcomes. This Mentored Patient-Oriented Career Development Award (K23) will
provide me with the training and mentorship needed to become an independent clinician-investigator and
leader on transportation insecurity, social risk, and healthcare access for patients with ESKD. I am a family
physician and medical anthropologist trained in qualitative and health services research and bring a unique
perspective on how individual and community social context impacts healthcare. To achieve my long-term
research and career goal of improving patients’ access to health care services and addressing longstanding
health inequities, I need additional skills in (1) epidemiologic design and advanced quantitative analysis skills;
(2) policy development and evaluation in transportation and ESKD, with emphasis on quality metrics; (3)
clinical intervention development and implementation of future transportation solutions. I will accomplish the
study’s goals through the following aims.
Aim 1: Quantify social risk levels in a diverse group of patients with ESKD treated with in-center HD
and associations with key HD outcomes in a prospective cohort study of 300 patients using the
Accountable Health Communities (AHC) instrument.
Aim 2: Assess the predictive validity of a novel transportation screening tool, the Transportation
Security Index (TSI), in HD settings to identify patients most likely to miss HD appointments and
compare its performance to the AHC’s transportation question.
Aim 3: Identify facilitators and barriers to home dialysis as a component of addressing transportation
insecurity in the ESKD population by conducting semi-structured interviews with patients, dialysis staff,
and policy makers.
The current proposal aligns with NIDDK’s priority area of developing interventions to integrate social and
medical care to improve health equity and will break new ground by evaluating social risk within the ESKD
population, with a focus on transportation insecurity.

Public health relevance
PROJECT NARRATIVE Persons with end stage kidney disease (ESKD) depend on reliable transportation to dialysis sessions. This Mentored Patient-Oriented Career Development Award will provide foundational data on the social risks faced by patients with ESKD treated with dialysis and how to best measure the transportation insecurity they face. It will lay the groundwork for future studies on screening and interventions to address health related social risks in the ESKD population with the goal of improving health and advancing equity.